Administrative Core

PROJECT SUMMARY (See instructions): The primary goal of the Administrative Core is to provide overall scientific, operational, and financial coordination of this Program Project. The Program Director and Core personnel work closely to ensure that the administrative needs of this diverse program are met in a timely and cost effective manner. The Core personnel provide comprehensive secretarial assistance to the Project and Core Directors. Core personnel will organize the conferences of the Scientific Advisory Panel. From this Core, the Program Director will maintain the balance between the Program and needs of each Project and Core through formal and informal meetings, email and telephone conversations. Core A personnel have a long-term association with this Program Project and have demonstrated the ability to efficiently and smoothly manage the operation of this large, diverse program.

Public health relevance
RELEVANCE (See instructions): The Administrative Core provides services that minimize the time and effort Program Project investigators spend on administrative and clerical functions. This in turn promotes the success ofthe research conducted by Program Project personnel and advances the programs contribution to public health.